Lipidomic predictors of heart failure in chronic kidney disease

ABSTRACT
Chronic kidney disease (CKD) is a major public health issue. Cardiovascular diseases (CVD)s are the leading
causes of morbidity and mortality in CKD, with heart failure (HF) being a major cardiovascular (CV) event. HF
is characterized by significant myocardial and systemic lipid metabolic derangements. However, the time
course of metabolic alterations in regard to functional, morphological and clinical presentations is not
established, nor the role of lipid metabolic derangements in pathogenesis of HF is investigated. Therefore, it is
unclear if the lipid metabolic alterations are cause or effect. We hypothesize that alteration in lipid metabolic
pathways predicts metabolic incident HF among CKD patients, and that metabolic incident HF is continuum of
a process that starts with alterations in lipid metabolic pathways that leads to changes of left ventricular (LV)
configuration, and eventually manifests as clinical HF. To test this hypothesis, we will pursue the following
specific aims: 1) To identify the lipidomic predictors of incident HF in CKD patients with and without diabetes,
2) To determine the lipidomic determinants of LV configuration in CKD with and without diabetes, and 3) To
explore differential lipid networks discriminating CVD phenotypes in CKD patients with and without diabetes.
Methods: This is an observational longitudinal study with prospective data on CV events. Study will be
performed on participants of the Chronic Renal Insufficiency Cohort (CRIC) as the training subset, and the HF
patients at the University of Michigan as the validation cohort. Inclusion criteria: baseline eGFR>30 mL/min,
availability of 200 µL of plasma sample at enrollment, echocardiography at year 1 (CRIC), and CVD outcome
data at follow up. Sampling: After implementation of inclusion and exclusion criteria 2931 patients from CRIC
including 341 with HF, and 1148 participants for validation cohort including 610 patients with HF matched by
538 participants without HF are selected. Predictors: mass spectrometry based quantified values of free fatty
acids (FA)s, acylcarnitines (AC)s, and complex lipids consisting of glycerolipids, phospholipids, and
sphingomyelins. Outcomes: Primary outcome for aims 1 and 3 is incident HF. Primary outcome for aim 2 is
echocardiographic assessment of LV configurations. Analysis: For aim 1, the analysis will include utilization of
adjusted Cox regression models with sequential lipidomic measurements at baseline and prior to outcome to
identify time-varying independent lipid predictors of incident HF. For aim 2, the analysis will include utilization
of partial least square-discriminant analysis (PLS-DA), random-forest, mixed linear models, and penalized
multinomial regression models to discriminate 4 categories of LV configurations. For aim 3, the analysis will be
based on Differential Network Enrichment Analysis (DNEA) to identify differential network of lipids
discriminating the study outcomes. Expected outcomes: It is expected that a differential panel of FAs, ACs, and
complex lipids at baseline predict incident HF and differentially correlate with LV morphology. It is also
expected that DNEA will disclose lipid metabolic pathways that are differentially regulated by study outcomes.

Public health relevance
NARRATIVE Although alterations of circulating lipids are reported in heart failure, it is unclear, if such alterations precede incident heart failure. In this project, we will test, if differential alterations in plasma lipids predict incident heart failure, and if they are linked with alterations of left ventricular morphology in chronic kidney disease patients with and without diabetes. Identification of lipidomic predictors of incident heart failure, may identify targets amenable to intervention prior to development of heart failure.